The impact of DNA supercoiling and topoisomerases on neuronal activity-dependent chromatin organization

PROJECT SUMMARY
Experience-driven changes to chromatin architecture help activate gene transcription programs that allow
animals to learn and develop adaptive behaviors. Yet the forces that remodel chromatin in response to neuronal
activity remain obscure. Torsion from DNA supercoiling injects free energy into the DNA and has the potential to
organize chromatin, yet how dynamic supercoiling distributes and acts within the neuronal genome are poorly
understood. RNA polymerases (RNAPs) and DNA topoisomerases generate and resolve supercoils,
respectively, and their concerted actions affect dynamic supercoiling distribution. However, to what extent
supercoils propagate from the sites of RNAP activity, and how chromatin structure affects supercoil distribution
remain unexplored. Furthermore, while supercoiling is a ubiquitous feature of DNA topology, how torsional free
energy from supercoiling affects chromatin structure and gene activity patterns is also unknown.
To address these issues, psoralen crosslinking and sequencing (TMP-seq) was recently performed to map the
distribution of underwound (negatively supercoiled) DNA at high resolution in cultured mouse cortical neurons
under basal conditions. Additionally, new methods were developed to map genome-wide sites of catalytically
engaged topoisomerases (TOP1cc-seq and TOP2Bcc-seq). These studies revealed that supercoils transmit
widely (> 200 kb) from the sites of active RNAPs, while topoisomerases only act at selective locations to resolve
supercoils. These data indicate that torsional free energy from supercoiling could be widely available to influence
chromatin structure. Based on these results, this project will perform TMP-seq at various times following neuronal
stimulation and assess how activity-driven supercoiling distributes within the genome. Additionally, TOP1cc-seq
and TOP2Bcc-seq will be performed under the same conditions to determine how topoisomerases are utilized
to regulate dynamic supercoiling in stimulated neurons. While supercoils generally distribute freely within
chromatin, preliminary data indicate that they also accrue at specific nucleosome configurations, particularly at
active promoters with broad H3K4me3 distributions and in regions flanking H3K27me3-rich chromatin.
Intriguingly, a broadening of H3K4me3 has been observed following neuronal stimulation in vivo, suggesting that
specific stimulus-driven epigenetic changes could “constrain” dynamic supercoils. The proposed research will
test this idea by assessing how knockdown of WDR5, which mediates H3K4 methylation, and expression of
JMJD3, which erases H3K27me3, affect neuronal activity-dependent supercoiling patterns. Finally,
topoisomerase inhibitors and locus-specific modulators of DNA supercoiling will be used to perturb supercoiling
patterns in stimulated neurons, and chromosome conformation capture (Micro-C), ATAC-seq, and nascent
transcription analysis (fastGRO) will performed to test the idea that dynamic supercoiling has a causal role in
neuronal activity-driven chromatin reconfiguration. Together, these efforts will provide new insights into how DNA
mechanics regulates neuronal functions during development and disease.

Public health relevance
PROJECT NARRATIVE Molecular forces that modify chromosome structure are crucial for establishing gene activity that allow animals to learn and generate adaptive responses, yet the identity of these mechanisms remains obscure. Our data suggests that torsional stress generated during transcription propagates widely across the neuronal genome and could be a driving force for chromatin reconfiguration following neuronal stimulation. By mapping the distribution of torsional stress at high resolution, and studying how torsional stress impacts chromosome configuration in response to neuronal stimulation, this project will enhance fundamental knowledge of how DNA mechanics shapes genome function, and mismanagement of torsional stress could contribute to neurodevelopmental defects and various neurological diseases, including autism spectrum disorders.